Acquisition of a Focused Ion Beam - Scanning Electron Microscope with Cryo Stage

Abstract
The goal of this proposal is to secure funds to acquire a Zeiss Crossbeam 550 Field Emission Scanning Electron
Microscope (SEM) with an Ion-sculptor Focused Ion Beam (FIB) column and a Quorum PP3010Z cryo-stage to
support NIH-funded research efforts at Emory University and member institutions of the Georgia Core Facilities
Partnership (GCFP). The cryo-FIB-SEM instrumentation will allow researchers to carry out three-dimensional
(3D) analysis of biological samples under room temperature and cryogenic conditions. This equipment will be
used to investigate cellular ultrastructure in 3D with enough resolution to observe details of cellular organelles
and generate quantitative data. The dual beam system allows for multiple sample types to be processed and for
electron tomography (ET) data to be obtained in situ, or through downstream cryo-ET of FIB-milled lamella. This
equipment will have direct applications in disease biology research, benefiting projects investigating infectious
diseases (Melikian, Sarafianos, Liang, Neufeldt, and D’Souza), neurodegenerative disorders (Smith, Kukar, and
D’Souza), heart conditions (Kwong), liver diseases (Yang), cancer (Yang, Liu, and Moniri), and the development
of therapeutics and diagnosis systems (Sarafianos, Yang, Banga, and Chougule). The instrument will be housed
and administered by the Robert P. Apkarian Integrated Electron Microscopy Core (IEMC), with an established
infrastructure for equipment administration, maintenance, and management, and an exceptional staff to support
research and train investigators in sample preparation, data acquisition, and processing. In summary, acquisition
of a cryo-FIB-SEM will offer imaging capabilities currently unavailable for biomedical research at Emory and
other regional institutions. It will have an immediate and profound impact on their projects by allowing image
acquisition on site, direct feedback from researchers, training of junior and senior investigators in FIB-SEM
applications, rapid turnaround to produce results for publications and grants, and a reduction in research costs
by removing the need for outsourcing.

Public health relevance
Project Narrative The Focused Ion Beam – Scanning Electron Microscopy (FIB-SEM) technology will allow biomedical investigators in human health and human diseases to understand the three-dimensional organization of cellular environments and have access to technology currently not available at Emory University or the region. The Zeiss Crossbeam 550 with a cryo-stage will support structural research of cells and macromolecular complexes involved in infectious diseases, neurodegenerative disorders, heart and liver conditions, and cancer. Acquisition of this FIB-SEM equipment with cryo-capabilities will have an immediate and profound impact by supporting a number of NIH-sponsored investigators at Emory University and members of the Georgia Core Facilities Partnership, who enjoy shared-access to each other’s state-of-the-art facilities, but still have a fundamental need for such high-end instrumentation.